Pain and Immobility After Breast Cancer Surgery: A Community-Based Randomized Controlled Trial of Myofascial Massage Treatment

ABSTRACT
About 25-50% of women who undergo breast cancer surgery develop persistent chest wall pain
and shoulder mobility limitations following surgery. The pain and mobility limitations adversely
affect quality of life, sleep, and body image. Unfortunately, current treatments for pain and
mobility limitations have variable efficacy. Based on a review of relevant pre-, intra-, and post-
operative factors, we reasoned that myofascial massage may address contributors to pain and
mobility limitations following breast cancer surgery. Myofascial massage is a deep tissue
massage that focuses on muscles as well as the connective tissue that surrounds muscles,
bones, and ligaments. We subsequently conducted a pilot randomized controlled trial involving
21 women with persistent pain and mobility limitations many months after surgery. We found
that women who received myofascial massage to the affected breast/chest/shoulder had
marked reductions in pain and mobility limitations and significant improvements in quality of life
compared to a control group who received relaxation massage. We also established a practice-
based research network of 63 northeast Ohio massage therapists to guide future work.
We now propose a full scale randomized controlled trial involving 202 women with persistent
pain and mobility limitations. To help differentiate between the specific effects of myofascial
massage and non-specific effects due to prolonged touch and attention from a massage
therapist, we will include an active control group that will receive light touch. Participants in
each group will receive 30 minutes of treatment twice weekly for 2 months. Primary analyses
will determine the impact of myofascial massage on pain and mobility limitations. Secondary
analyses will examine the impact of myofascial massage on a number of secondary outcomes,
including range of motion, quality of life, sleep, and body image.
Innovative features of the proposed project include a rigorous randomized controlled trial
design, inclusion of an active control group, direct targeting of the affected
breast/chest/shoulder, assessment of multiple mechanistic and patient-centered outcomes, and
involvement of a massage practice-based research network. We anticipate that the project will
lead to a new and effective approach for addressing a major source of morbidity for women with
breast cancer. Furthermore, the project may serve as a model for future trials of manual
therapy among individuals with chronic medical conditions.

Public health relevance
PROJECT NARRATIVE Many women have persistent pain and mobility limitations following breast cancer surgery. The goal of this project is to determine if deep tissue massage will reduce pain, improve mobility, and enhance quality of life.